Extending the utility and performance of variant effect predictors with protein language models

Project Summary
Variant effect prediction (VEP); the process of determining the impact of amino acid alterations in a protein
sequence, remains a fundamental challenge across both clinical and research domains. Despite the extensive
application of existing VEP methods, their overall impact is limited, with most variants labeled “variants of
unknown significance”. This research project aims to overcome these limitations in VEP, harnessing the
potential of protein language models (PLMs) which have already shown widespread success in other fields,
and integrating complementary sources of information, as employed by current methodologies, to enhance the
understanding and prediction of genetic variants' functional impact on proteins and complex traits. The specific
aims include: 1) Enhancing the core functionality of VEP models by providing robust estimates of score
uncertainty and experimentally validating whole haplotype effect scores, including predictions of epistatic
interactions. 2) Improving VEP model performance by integrating PLMs with external information such as 3D
structural and homology data and fine-tuning them on functional assays and clinical databases. 3) Improving
the discovery and clinical interpretation of functional protein-altering variants by optimally utilizing
computational annotations and analyzing whole haplotype data in the context of gene-trait associations and
clinical settings. This research project builds upon our strong preliminary data of PLM-based variant effect
prediction, which by multiple metrics has demonstrated best-in-class performance. By leveraging PLMs and a
variety of external data, this project aspires to advance the field of variant effect prediction, enabling a more
profound understanding of genetic alterations, and improving diagnostic and prognostic medical exome
sequencing.

Public health relevance
Project Narrative This research project seeks to improve our understanding of how genetic changes impact protein function and human health. We will develop advanced computational methods to predict the effects of genetic variations more accurately and integrate diverse sources of information to enhance these predictions. Our work will pave the way for better diagnosis and treatment of genetic diseases, as well as advancements in personalized medicine.